Development, field testing and evaluation of the efficacy of a hand-held, portable and affordable thermo-coagulator to prevent cervical cancer in low- and middle-income countries -admin supplement

Supplement to Original NCI Grant No: 5UH3CA202721-05
Project summary
A study nested in the cervical cancer screening programme in Lusaka, Zambia was initiated
in July 2016 with the general aim of developing, evaluating, and validating a robust, user-
friendly treatment device for cervical cancer precursors suitable for settings with limited
medical resources. The study was implemented in two phases – UH2 and UH3. UH2 phase
of the study successfully developed a battery-driven lightweight affordable thermal ablator
(a.k.a. thermo-coagulator) from its prototype stage and evaluated the same in a pilot
randomized trial. The ongoing UH3 phase study is a larger randomized controlled trial that
aims to compare the efficacy, acceptability, and safety of thermal ablation with other `standard
of care' techniques to treat cervical precancers (cryotherapy and LLETZ) in `screen and treat'
setting in Zambia. The primary objective of UH3 phase randomized controlled trial is to
compare the treatment success rate of thermal ablation to that of cryotherapy and large loop
excision of transformation zone (LLETZ aka LEEP) to treat VIA positive women who are
eligible for ablative treatment. The study aims to recruit 3,123 VIA positive women (equally
distributed across three treatment arms) and follow them up at 12 months post-treatment to
achieve adequate statistical power. Due to the disruptions created by the COVID pandemic in
Zambia it was not possible to complete the targeted recruitment within the stipulated time and
funding was utilized to protect and support the participants and project staff, increase the
number of study sites (by three times) to maintain recruitment target, pay for the COVID
mitigation measures and retain all the study staff. We need to recruit an additional 524
participants and follow them over 18 months.

Public health relevance
Supplement to Original NCI Grant No: 5UH3CA202721-05 Project narrative An ongoing UH3 phase randomized controlled trial nested in the cervical cancer screening programme in Zambia aims to compare the efficacy and safety of thermal ablation in treating cervical precancer to that of existing standard of care techniques, namely cryotherapy and LLETZ (large loop excision of transformation zone). Due to the COVID pandemic induced disruptions the study could not complete the targeted recruitment of 3,123 screen positive women within the stipulated time. The administrative supplement is to request additional funding to complete the study, which otherwise will be underpowered to address the key research question of great public health significance for the low and middle income countries.